Rapid and Automated Dissociation of Tumor Tissue for Single Cell Diagnostics

ABSTRACT
Solid tumors are diverse ecosystems of different cell types, and this heterogeneity has been
implicated as a key factor driving disease progression, metastasis, and drug resistance. Assessing
cellular heterogeneity and identifying key driver cells, such as cancer stem cells, has thus become a
critical factor for understanding tumor biology. These issues are also important for clinical
diagnostics, as targeted therapies must be directed toward the most important cell types if effective
cures are to be achieved. Increasingly, single cell analysis methods are being used to define cellular
subsets within tumors to address biological and therapeutic questions. However, the need to first
convert tissue into single cells is a significant barrier to more widespread use, particularly in clinical
settings. Current tumor dissociation methods are long, inefficient, and not standardized. Moreover,
there remains a question as to whether different cell subtypes are easier to release than others,
leading to results that may not accurately reflect the original tumor. In previous work, we have
developed a novel microfluidic device containing an array of branching channels that can dissociate
cell aggregates and partially digested tissue in minutes with dramatically higher yield of viable
single cells. In this proposal, will significantly improve the power and commercialization potential of
this microfluidic tissue dissociation device by combining it with a CD microfluidic technology to
create a fully automated CD-lab on a chip (CD-LOC) platform called the Syntrfuge. This will
dramatically increase operational versatility, including increasing flow rate by 100x compared to a
pump, which will significantly improve dissociation efficiency and decrease processing time.
Furthermore, the likelihood of channel clogging will be reduced by direct application of centrifugal
forces to tissue fragments and cellular aggregates. Finally, the system will be fully self-contained to
maintain sterile conditions and protect the operator. The performance of the Syntrfuge will first be
optimized using a murine tumor model, followed by final validation using human tumor tissue
specimens. All tests will focus on single cell yield and viability, and the final evaluation will include
single cell RNA sequencing. The Specific Aims for this 6 month project include: (1) optimize the
Syntrfuge using a murine breast tumor model and (2) Validate performance of the final platform
using human tumor tissue specimens. Our microfluidic device platform technology will directly
impact single cell analysis of tumor specimens, particularly single cell sequencing, an emerging
and potentially transformative molecular analysis tool. This will be achieved by streamlining tumor
tissue dissociation through automation, increased efficiency, elimination of pre-processing (i.e.
scalpel mincing), and continuous generation of 100% single cells. We are confident that this
mechanical processing approach will be viewed favorably by the FDA and provide the data needed
to move on to Phase II studies.

Public health relevance
Public Health Relevance Statement New diagnostic methods that enable molecular characterization of the diverse cell types that comprise a solid tumor could provide clinicians with valuable information for treating cancer patients. In particular, single cell sequencing holds potential to transform our understanding of tumors and help usher in the age of precision medicine, but the technical challenge of extracting the cells from tissue remains a major barrier. The proposed project seeks to address this technical challenge by developing a commercial CD-microfluidic platform technology that will make single cell isolation faster, more efficient, and fully automated. Once developed and characterized, the CD- microfluidic device will be dramatically advance single cell studies for tumor specimens in research and clinical laboratories.